PULSE INTRAVENOUS CLOMIPRAMINE IN DEPRESSED ADOLESCENTS

The hyposerotonergic hypothesis of adolescent depression (MDD) is examined via 3 pathways: 1) low dose (12.5 mg) IV clomipramine (CMI) as a serotonergic probe in adolescent MDD compared to matched controls as a potential marker, and assessment pre and post treatment with an SRI as a potential trait marker of MDD in this population; 3) use of high dose (200mg) pulse IV CMI (an SRI when given IV) to determine acute efficacy in adolescent MDD.